Imaging and Genomic Signatures of Brain Tumor Heterogeneity and Evolution to Optimize Patient Management

OVERALL: PROJECT ABSTRACT
The overall goal of this renewal P01 proposal is to identify imaging and genomic signatures of brain tumor
heterogeneity and evolution to optimize patient management of the two most common primary brain tumors in
adults: glioblastoma and meningioma. The hallmark of glioblastoma is resistance to standard treatment with
rapid progression at the time of recurrence. Although meningioma can be slow growing, a major proportion recur
following standard surgery and radiation with a significant adverse impact on survival. A new, prognostically
distinct, classification of meningioma based on DNA-methylation was recently developed. This renewal P01 will
establish non-invasive imaging correlates of mechanistic genomic drivers of tumor evolution and intra-tumoral
heterogeneity (Projects 1 and 2), to uniquely identify new therapeutic targets that can be rapidly evaluated by
biologically relevant imaging metrics to assess early response to treatment (Projects 3 and 4).
Building upon the demonstration of genomic heterogeneity in these lesions along with the recent technical
advances in 1H and hyperpolarized 13C metabolic imaging that have facilitated the successful translation of [1-
13C] and [2-13C]-labeled pyruvate and enabled the development of a new imaging probe ([1-13C]alpha-
ketoglutarate) we will: i) elucidate spatial and temporal imaging correlates of genomic underpinnings of
intratumor heterogeneity and their functional impact in glioblastoma that confounds therapies (Project 1); ii)
characterize meningioma evolution and heterogeneity by defining genomic mechanisms and therapeutic
vulnerabilities that underlie imaging features of intratumor molecular heterogeneity (Project 2). 3-D imaging
models of genomic data will be generated in both Projects 1 and 2 with additional synergistic interactions based
approaches applied. Using 1H- and hyperpolarized 13C- MRS markers of NF2 loss and FOXM1 expression,
Project 3 will identify metabolic imaging biomarkers in the preclinical setting that can stratify molecular groups
of meningiomas. Project 4 will expand on Projects 1, 2 and 3 to develop and optimize novel 1H and 13C metabolic
imaging methods in patients in order to monitor early response to targeted therapy in recurrent glioblastoma,
and determine metabolic features of meningioma gene-expression groups, including with the development of a
new [1-13C]alanine probe. The Administrative & Clinical Services, Biospecimen & Biomarker, and Imaging Tumor
Heterogeneity & Metabolism Cores will be critical for directing and supporting all of the projects.
Leveraging the expertise, unique infrastructure at UCSF, translational strengths of the investigators, and
achievements to date from the current P01 and other NCI grants, the pioneering fundamental and translational
cancer research described in this proposal will accelerate the implementation of innovative experimental
genomic and metabolic imaging techniques. This rapid translation of non-invasive metabolic imaging and
genomic signatures to assess brain tumor heterogeneity and evolution will provide new insights into potential
therapeutic targets, enhance the evaluation of novel therapies, and assist in the optimal patient management.

Public health relevance
OVERALL: PROJECT NARRATIVE The overall goal of this renewal P01 proposal is to identify imaging and genomic signatures of brain tumor heterogeneity and evolution to optimize patient management of the two most common primary brain tumors in adults: glioblastoma and meningioma. This will be achieved by integrating multi-parametric imaging strategies assessing spatial and temporal changes in individual patients during the course of their disease along with genomic properties of the tumor. We will ascertain non-invasive imaging markers that reflect the underlying biological mechanisms driving glioblastoma evolution and mengingioma molecular differentiation to improve patient care through informing new therapeutic targets and ways to monitor early response.